The Role of Fgf Signaling in Vertebrate Development

The long term goal of this project is to understand how an important family of signaling ligands, called Fibroblast Growth Factors (FGFs), control a wide spectrum of cell biological behaviors such as proliferation, cell death, migration, stem cell maintenance and gene expression. In particular, we use complex mouse genetics to understand the role of FGF signaling in mesodermal lineages with a special emphasis on extension of the body axis and formation of somites (segmented mesodermal segments that are the building blocks of vertebrate muscle, dermis and vertebral bodies). Our work has made clear that genetic redundancy is an important aspect of this biology; therefore all work in this project emerges from an effort to comprehensively characterize the genetic redundancy of FGF signaling in the mesodermal lineage. Such work is relevant to many cases of cancer where more than one FGF gene may be damaged. To achieve this, we have generated and characterized important Cre mouse lines, which are tools that allow the control of gene expression in the early embryo. These include TCre (expressed in the early emerging nascent mesoderm; see Development. 132: 3859-71. ), TCreERT2 (active in emerging nascent mesoderm at all embryonic stages; see PLoS ONE. 8: e62479) and Tbx4-Cre (expressed in a posterior mesodermal domain that includes the allantois, hindlimb, and external genitalia; see Dev Dyn. 240: 2290-300. doi: 10.1002/dvdy.22731). TCre, in particular, has had a major impact on the field, being essential in over 50 publications. For example, both TCre and TCreERT2 have important in a collaborative effort to demonstrate that Wnt5a/Ror2 signaling regulates kidney morphogenesis by controlling intermediate mesoderm extension (Hum Mol Genet. 2014 Jul 31. pii: ddu397). Besides providing the mouse genetics community with valuable mouse lines, this project has yielded papers that document our major insights regarding FGF signaling in the early embryo. We published that Fgf8 not required for somitogenesis, although a body of high-profile work had placed it in a central position in current models. However, in collaboration with NCI colleague, Alan Perantoni, we demonstrated that Fgf8 was essential for development of the kidney and male reproductive tract (Development. 132: 3859-71, Development. 138: 5369-78). A feature of these mutants was aberrant cell death due to loss of Fgf8 signaling. In 2023, we published a study, showing we can restore cell survival to such mutants, by removing the pro-apoptotic genes, Bax and Bak. This genetic manipulation restores some measure of kidney development, but nephrogenesis is not normal, revealing new insights into Fgf8 function in this process (Differentiation, 2023, 130:7-15). We showed that Fgf8, together with Fgf4, are required for essential aspects of somitogenesis: expression of oscillating gene domains, WNT pathway genes and markers of undifferentiated presomitic mesoderm (Proc Natl Acad Sci U S A. 108: 4018-23). By examining FGF mutants in which we genetically restored WNT signaling, we demonstrated that FGF signaling operates independently of WNT signaling in this process. The functional redundancy that we uncovered has implications for cancer as both FGFs have been found to be aberrantly active in testicular tumors. In recent studies we have delved deeper into this work and have shown that Fgf4 mutants (but not Fgf8 mutants) display a range of vertebral defects that model a spectrum of human Segmentation Defects of the Vertebrae caused by defective Notch oscillations. A key innovation in this work is our adaption of computational modeling to generate embryonic volumetric subsets of the embryo. We then quantify mRNA levels of key target genes, affected by the loss of Fgf4 signaling, within these volumes (eLife 2020;9:e55608. DOI: https://doi.org/10.7554/eLife.55608). We applied this technical innovation in a collaborative study published with the Kwon lab at Johns Hopkins Medical School on the role of WNT signaling in heart development (Proc Natl Acad Sci U S A., 2023, 120(4):e2217687120). In another recent publication, we demonstrated that the Fgf8 subfamily (Fgf8, Fgf17 and Fgf18) are required for closing the ventral body wall in the vertebrate embryo. Defects in this process are a major class of human birth defect and a significant health burden (Development (2020) 147, dev189506. doi:10.1242/dev.189506). In recent work we collaborated with the Rocha lab (NICHD) to study how chromatin domains, controlled by CTCF sites, regulate the expression of FGF genes. Specifically, we studied the developmental consequences of disrupting the chromatin domain wherein reside three FGF ligand genes-Fgf3, Fgf4, and Fgf15. This work concluded that small sequence variants at particular domain boundaries can have a surprisingly outsized effects and must be considered as potential sources of gene dysregulation in development and disease (Dev Cell 2025, 60(13):1838-1853). We are continuing to study genetic redundancy in FGF signaling in several aspects of embryonic development. We are currently focusing on two aspects of development: generation of the primitive streak, which generates all embryonic mesoderm and differentiation of the somite into its derivative lineages (muscle and bone). Additionally, we are completing a study characterizing the role of the transcription factor, HIF1a, in early development. HIF1a is a key responder to oxygen levels in all cells and is activated when cell are hypoxic. Previous studies have shown that hypoxia dysregulates FGF signaling in axis extension and somitogenesis. Therefore our work will define the link between these two essential pathways: FGF signaling and the oxygen-sensing machinery.